Visual-search ideal observers for modeling reader variability

Project Summary/Abstract
The goal of this project is to develop novel methods for predicting human decisions with diagnostic
images. Expected project outcomes include new insights into sources of radiologist variability and
advanced tools to accelerate imaging trials in clinical research. Such trials with expert readers and
known-truth cases are an accepted but burdensome gold standard for evaluating imaging technology.
The necessary trial resources are not available to many clinical researchers. Virtual trials with sur-
rogate model observers have been proposed, but important limitations, including primarily correlative
estimates and persistent model reliance on human data for training, prevent their widespread adop-
tion. Quantitative models with minimal dependence on human input will substantially improve clinical
access to advanced imaging technology. Our approach to develop such “low-resource” models will
explore reader variability in target detection and estimation tasks. Ideal observers (IOs) derived from
gist-processing and extreme-value theories will be the starting point. These IOs are optimal for de-
cision processes that maximize over sets of extracted feature values, a common premise for tasks
involving visual search. The result will be adaptive observer models that produce tighter bounds on
human performance compared to existing models. These new models will test if reader variability
can be attributed to candidate pooling and cognitive threshold mechanisms that deﬁne image struc-
ture of interest. Analytic ﬁgures of merit for diagnostic visual-search tasks will be developed. We
will test model generalizability across radiological modalities, tasks, imaging models (e.g., simula-
tion/patient data), and reader classes (lay/clinician), all of relevance for researchers. The tasks will
include location-known, localization, and joint detection-estimation formats. The joint task compels
more precise information extraction than target detection alone; we hypothesize that detection perfor-
mance correlates with estimation skill, with the latter helping to resolve structure. We shall leverage our
ﬁndings to devise multireader virtual trial protocols for improved statistical rigor. Enhanced stochastic
target modeling for studies with 2D and 3D images will be supporting aims. The IO will also allow
examination of nonlinear behaviors for individual readers. The project studies relate to dose reduction
and reconstruction methods for x-ray and nuclear medicine modalities, but the methods can apply
more generally. By accelerating the clinical adoption of advanced imaging technology, our model
observers will have a direct and widespread impact on clinical operations and patient care.

Public health relevance
Project Narrative Multireader clinical imaging trials are a burdensome standard for assessing and comparing diag- nostic medical imaging technology. We propose to develop an adaptive computer model that can provide quantitative multireader performance estimates at clinically relevant tasks. This will improve the statistical rigor of in silico imaging trials, ultimately beneﬁtting patient care through faster, less costly adoption of imaging advances.